NCATS SCIENTIFIC AND TECHNOLOGY PROGRAM SUPPORT (STPS)

Shared collaborative cloud environment, including cloud-based productivity tools, a service desk, commercial and open-source deployments of analytical tools for the Rare Diseases Information Systems